Beginning and Early Stage Translational (BEST) Researchers

ABSTRACT
Significant disparities exist in health outcomes for rural and Black, Indigenous or people of color (BIPOC)
Americans. A contributing cause to these outcomes is the lack of diversity in translational researchers. To
enhance the translational science workforce, we have developed a summer research experience for
underrepresented undergraduate scholars who have previously completed a short program exposing them to
healthcare careers. Because the University of Iowa has a wide variety of research occurring across the
translational spectrum, extensive resources, and a unique role as the only academic medical center in a rural
state, we provide an ideal location for this training. The goals of our program are to provide 1) enhanced short-
term training in translational science, 2) mentoring of underrepresented future translational scientists, and 3)
focused education sessions related to clinical and translational science. To accomplish these goals, our
experiential educational opportunity for Beginning and Early Stage Translational (BEST) Researchers will
embed students in teams conducting translational research. Additionally, scholars will also participate in
educational experiences to provide them with foundational tools to progress to successful careers in
translational science. This will include seminars and activities related to bioethics, receiving mentorship,
wellness and resiliency, communication skills, advocacy for self-and others, application and interview tips,
responsible conduct of research, data management and analysis, and community participatory research. We
will utilize the Stanton-Salazar Social Capital Framework for helping scholars build strong relationships with
resources and support to advance them in the educational system. Further, our educational sessions will be
based on the backward curriculum design framework. This framework ensures that our goals for each session
are clearly delineated, and the activities are designed to support these goals. The Evaluation Program in the
Institute for Clinical and Translational Science at the University of Iowa will provide oversight that we are
achieving our goals and have continuous quality improvement. We will also evaluate the short and long-term
progress of the program’s scholars across several domains including improved domain skills, continued
participation in research, admission to graduate and professional programs, and submission and acceptance of
abstracts and manuscripts. In summary, there will be significant value in our program, and it will result in
improving diversity in the next generation of translational researchers which will ultimately contribute to our
efforts to reduce health disparities for rural and BIPOC populations.

Public health relevance
PROJECT NARRATIVE One step to combat health disparities is to increase diversity in the biomedical workforce, including translational scientists. This program will provide a unique opportunity for underrepresented undergraduate students to have hands-on experience performing translational research. In combination with educational activities, students will be given the foundational tools for successful careers in translational science and will enhance the future biomedical workforce.